The relationship between language and executive function in DLD and FXS over time

PROJECT SUMMARY/ABSTRACT
Language impairments have a persistent, lifelong impact on social communication, academic performance,
and adaptive behaviors. Clinical groups impacted by language impairments include developmental language
disorder (DLD), fragile X syndrome (FXS), and Down syndrome (DS). DLD affects 7-13% of school-age
children, and is characterized by pervasive impairments in the grammatical system in the absence of an
intellectual disability. Individuals with FXS and DS have significant language impairments, but unlike DLD,
language impairment is part of a constellation of broader developmental issues, including intellectual disability.
Notably, there is a significant overlap in the language phenotype between DLD, FXS and DS, in terms of
grammatical production. This is striking given the difference in general cognitive abilities between the groups.
Importantly, nothing is known regarding areas of overlap and distinction in grammatical comprehension
between these disorders. Additionally, although FXS and DS have very different cognitive profiles from DLD in
terms of IQ, there are overlaps in other aspects of cognition, namely executive functions. This is particularly
interesting, given evidence of a relationship between executive functions and language skills during typical
development as well as in children with DLD, however, this work is nonexistent in FXS and DS. Comparative
studies between disorders with known (FXS and DS) and unknown (DLD) etiology have the potential to inform
both theory and clinical practice. Thus, through this supplement we will test two specific aims designed to
systematically investigate areas of overlap and distinction in terms of language with a focus on grammatical
production and comprehension and the association with executive functions in children with DLD and FXS
(parent R01) and DS (supplement) in a developmental framework. Through careful investigations we will be
able to determine the relationship between grammatical comprehension and production in addition to executive
function skills in DLD, FXS, DS and a language matched group of children with typical development. For this
supplement, we propose to recruit children with DS (n = 20). For the parent project, we are recruiting children
with DLD (n = 40), children with FXS (n = 40), and children with typical development (n = 60). All groups will be
matched on clause length to ensure similar language abilities. This supplement will include a combination of
standardized assessments, language samples, experimental tasks, and parent report measures. The proposed
study will yield key information regarding children’s comprehension of grammar, best assessment methods,
and critical information on the relationships between executive functions and grammatical development. The
data collected in this study will be used to inform treatment studies designed to maximize both the
effectiveness and efficacy of language learning in DLD, FXS and DS in targeted intervention studies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it contributes to a program of research focused on significantly improving the communication abilities of children with language impairments, including children with Down syndrome (supplement), children with fragile X syndrome (parent grant) and children with developmental language disorder (DLD; parent grant). The proposed study will track language production and comprehension in school age children, considering the unique impact of one aspect of cognition (executive function). Given the prevalence of DLD (7-13% of school age children), and the significant overlap in the language phenotype between Down syndrome, fragile X and DLD, this project addresses the NIDCD’s mission to improve the lives of individuals with communication disorders.